Patient Assessment Resource Core (PARC)

ABSTRACT/ PROJECT SUMMARY
The primary objective of this Core Center for Clinical Research (CCCR) is to promote impactful
research in pediatric rheumatic and non-inflammatory musculoskeletal diseases (PMSKD) by
the local and national Research Community with a focus on enhancing well-established
research programs and institutional expertise in juvenile idiopathic arthritis (JIA), childhood-
onset systemic lupus erythematosus (cSLE) and juvenile-onset fibromyalgia (JFM). This
CCCR, which is called the Pediatric musculOskeletal & RheumaTology Innovation COre center
(PORTICO), will be served by a Patient Assessment Resource Core (PARC) which will offer
cutting-edge, age-appropriate clinical assessment tools for capturing the benefits of health
interventions and delineating PMSKD phenotypes. The proposed Director of PARC is Charles
Dumoulin, PhD and the Associate Director is Esi Morgan, MD, MSCE, both well-established
researchers. The specific aims of the PARC are: (1) Provision of state-of-the-art imaging
services to support research studies in PMSKD, (2) Development of new imaging-based
methods and scoring systems to assess the severity of PMSKD and the efficacy of novel
PMSKD treatments, and (3) Development of data display tools to quantify treatment impact as
measured by patient reported outcome (PRO) assessments, imaging data, and biomarkers for
research innovations to inform clinical decision making. With the PARC, PORTICO proposes to
establish an imaging core that is the first of its kind to focus on PMSKD and provide services
and greater access to innovative non-invasive imaging technologies (e.g. ultrasound, magnetic
resonance imaging, biomechanical assessment). Accelerating the Research Community work
in the area of functional MRI methods of neuroimaging will result in new discovery in
understanding of pain in JFM, JIA, and also in the study of neuropsychiatric manifestations of
SLE. Other areas include application of MRI to study of lung disease in systemic JIA and the
establishment of needed protocols and scoring systems in musculoskeletal ultrasound. PARC
will also support researchers to integrate PROs into research studies. In collaboration with
PORTICO's Methodology Core, PARC will provide the Research Community opportunity to pair
PROs with imaging references, biomarkers and genomic information in data--rich electronic
dashboard visualization in support of personalized medicine. Outreach and engagement with
multi-center rheumatology networks will extend the reach of these advances to the
rheumatology community in service to improving patient outcomes.